Vaccine-mediated control of bacterial virulence regulation and infection

PROJECT SUMMARY: Staphylococcus aureus (SA), including methicillin-resistant (MRSA), is
the most common cause of skin and soft tissue infection (SSTI) in the US. SA causes recurrent
infections, particularly in highly susceptible patient populations with reduced immune function. To
date, no vaccine to prevent SA infection has succeeded in human trials. Meanwhile, the need for
a vaccine continues to escalate, as does the ability of this pathogen to acquire antibiotic
resistance. We have developed a novel vaccine to control regulation of SA virulence factor
production. In models of skin infection, this vaccine induces antibodies that prevent activation of
this regulator system and protect against invasive infection. In this proposal, we aim to evaluate
the preclinical potential of this vaccine strategy. We will determine vaccine efficacy in multiple
models of SA infection as well as models of reduced immune function. Our results could lay the
groundwork for development of an efficacious vaccine to prevent SA infection and limit
pathogenesis. This vaccine could significantly improve the health of patients who suffer from
invasive SA infections.

Public health relevance
PROJECT NARRATIVE: Staphylococcus aureus (SA) is the most common cause of skin and soft tissue infection (SSTI). SA causes recurrent infections, particularly in highly susceptible patient populations with reduced immune function. We have developed a vaccine to control SA production of secreted factors that drive pathogenesis during infection. We aim to test the efficacy of this vaccine in models of reduced immune function. This vaccine could significantly improve the health of patients who regularly suffer from SA skin infections.